Optimization and development of extracellular matrix-targeting probes for PET-based assessment of lung fibrosis disease activity

Idiopathic pulmonary fibrosis (IPF) is a rapidly progressing disease characterized by relentless extracellular
matrix (ECM) deposition and lung stiffening that leads to death 3-4 years after diagnosis. IPF disease monitoring
largely relies on high-resolution computed tomography imaging and pulmonary function tests, which are unable
to assess ECM deposition or real-time disease activity. Since there is currently no method to evaluate ECM
deposition and real-time disease activity, and given the importance of determining disease progression in
therapeutic decision-making, there is a critical need for improved methods to assess IPF disease activity in real-
time. Dr. Bernau's long-term goal is to establish an independent research career dedicated to developing new
molecular imaging methods that facilitate diagnosis and treatment of disorders characterized by aberrant wound
healing, especially IPF. Molecular probes optimized for positron emission tomography (PET) imaging enable
sensitive assessment of target engagement, making this an attractive modality for non-invasive monitoring of
disease activity. In this proposal, Dr. Bernau will leverage her expertise in matrix biology of IPF, small animal
imaging with training in PET imaging, probe development, pharmacology, and additional animal models of lung
fibrosis to develop a novel PET probe optimized to determine the activity and treatment response of human IPF.
Fibronectin (FN) is an abundant glycoprotein that is highly upregulated during IPF, serves as a scaffold for
other ECM proteins, including collagens, and is localized to fibroblastic foci, the leading edge of active fibrosis.
Due to its essential role in early phases of the fibrotic process, the rationale for this proposal is that identifying
regions of nascent FN deposition can serve as a tool for distinguishing active fibrosis and assessing disease
progression. Dr. Bernau and her team developed a novel probe (PEG-FUD) that is innovative in its capacity to
target early ECM deposition in fibroblastic foci in human IPF and early pro-fibrotic phases of bleomycin-induced
pulmonary fibrosis in mice (via in vivo PET imaging). The objective of this proposal is to address the probe's key
characteristics for detection of fibrotic disease activity and adapt it for downstream clinical translation, including
optimization of its signal to background ratio within 1 h post-injection. To accomplish this, Dr. Bernau Aims to: 1)
Optimize FUD's imaging performance while preserving FN binding affinity in vitro and in vivo, and 2) Determine
how 64Cu-PEG-FUD probe can monitor disease progression and response to antifibrotic therapies. Dr. Bernau
is supported by the rich research infrastructure and resources of her Mentorship and Advisory Committee, the
Department of Medicine, and the University of Wisconsin-Madison. These studies will enable Dr. Bernau's future
work focused on subsequent pre-clinical developments of PEG-FUD as a probe for active lung fibrosis.
Importantly, this project and training period will serve as a foundation for an independent research career focused
on molecular probe development for IPF and other disorders characterized by aberrant wound healing, informing
the choice of optimal treatment and improving morbidity and mortality for these devastating conditions.

Public health relevance
PROJECT NARRATIVE Assessment of active pulmonary fibrosis, a progressive, fatal disease characterized by unrelenting scarring and stiffening of the lungs, is critical for appropriate therapeutic treatment. This project is relevant to public health as it aims to determine the capacity of a novel positron emission tomography (PET) probe to accurately detect pulmonary fibrosis disease activity in mice and chemically optimize it to enable future clinical translation. These studies will serve as a foundation for future clinical applications of this PET-based probe as a non-invasive method for assessment of activity for this deadly disease, in order to determine best treatment for patients, reduce their illness, and lengthen their lives.